Research Fellowship in Geriatric Mood Disorders

Title: Postgraduate Research Fellowship in Mid- and Late-Life Mood Disorders
PROJECT SUMMARY
This is the 7th competing application of this T32 Research Fellowship Program in Mid- and Late-Life Mood
Disorders, which has been offering multidisciplinary training for 30 years. This successful T32 has undergone
continuous transformation in response to scientific developments, NAM mandates, the 2020 NIMH Strategic
Plan Draft Priorities, the RDoc Project, and the evolving expertise of our faculty. The new T32 organizes its
research training in a continuum in which our human neurobiology studies provide targets for our novel
treatment development initiatives and our services research seeks to extend the quality and reach of mental
health treatment in the community.
The Program's strengths are: 1) The academic record of its trainees; the 13 fellows trained over the past 10
years received 3 K Awards, a 4th K Award received a priority score of 16 in the Study Section of March 2020,
and coauthored 82 papers (41 first-authored); 2) Leadership in research training at a national level (PIs of the
NIMH Research Career Institute in Mental Health of Aging and faculty of the NIMH Advanced Research
Institute); 3) NIMH-funded faculty in studies ranging from molecular genetics, neuroimaging, clinical
pharmacology, intervention development, and mental health services; 4) Cohesive organization of the Weill-
Cornell Institute; 5) Ten Cornell pilot project programs; 6) Rich study populations and laboratory resources; 7)
Databases available for secondary analyses and hypothesis generation by fellows; 8) Long and effective
collaboration with investigators of Geriatric Medicine, General Internal Medicine, Services Research Program,
Public Health, and Medical Ethics; and 9) Leadership in 8 multisite studies.
The Program will be directed by funded investigators in clinical biology (F. Gunning), novel treatment
development (G. Alexopoulos) and community studies (J.A. Sirey) with a strong record in research training and
by an Executive Committee with expertise in molecular genetics, neuroimaging, treatment development, and
diversity studies. We request support for 3 trainees, whose personalized training programs will be coordinated
by a primary and a secondary mentor and specialized advisors to facilitate translation research. Beyond a
Core Curriculum, we support our trainees in conducting their own studies, in preparing funding applications,
and in publishing data-based papers.

Public health relevance
PROJECT NARRATIVE This Research Fellowship has prepared many generations of physicians and Ph.D. scientists for a successful research career in geriatric mood disorders over 30 years. We have transformed our training in response to changes in science, the National Academy of Medicine mandates, the 2020 NIMH Strategic Plan Draft, the RDoC Project, and the evolution of our research team. We request to extend the fellowship for another 5 years, as we believe that our future ability to reduce the burden of mid- and late-life mood disorders rests on the development of tomorrow's science leaders.